mTORC1 Regulation by Upstream Stimuli

ABSTRACT
The mammalian target of rapamycin (mTOR) is an evolutionary conserved Ser/Thr kinase that senses multiple
upstream stimuli to regulate cell growth, metabolism, and autophagy. mTOR is the catalytic component of a
multi-protein complex called mTOR complex 1 (mTORC1). Elevated mTORC1 activation is common in multiple
human disease including cancer, type 2 diabetes, metabolic disorders, and neurodegeneration. Small molecules
like rapamycin that target and inhibit mTORC1 are used in the clinic with limited success. Thus, deciphering the
molecular mechanisms by which mTORC1 is regulated is crucial to treat mTORC1-mediated disease. The
overall objective of this proposal is to decipher the molecular mechanisms by which mTORC1 is regulated by
upstream stimuli. Specifically, this proposal is focused on mTORC1 regulation by amino acids and G-protein
coupled receptors (GPCRs). We anticipate that the studies in this proposal will yield new insights into mTORC1
regulation by upstream stimuli and will uncover novel therapeutic targets to perturb mTORC1-mediated disease.

Public health relevance
PROJECT NARRATIVE The mammalian target of rapamycin complex 1 (mTORC1) integrates multiple signals in order to control cell physiology. Increased mTORC1 activation is frequently observed in human disease, including cancer, type 2 diabetes, metabolic disorders, and neurodegeneration. The goal of this MIRA is to elucidate the molecular mechanisms by which mTORC1 is regulated by upstream stimuli. Completion of this project will provide valuable insight about mTORC1 biology and will uncover novel therapeutic targets.